SWI/SNF in ultraviolet radiation-induced chromatin alterations

Cutaneous malignant melanoma, the most lethal form of skin cancer, originates from the
transformation of epidermal melanocytes. The primary environmental risk factor for melanoma is
exposure to ultraviolet radiation (UVR) from sunlight. UVR induces DNA damage, inflammation,
and various cellular alterations that culminate in the conversion of melanocytes into melanoma
cells. Under normal circumstances, melanocytes respond to UVR by orchestrating genomic
changes that facilitate a photo-protective response. This includes crucial processes such as
melanin synthesis, modifications to the cell cycle, activation of DNA repair mechanisms, and
initiation of cell death pathways. The development of melanoma can arise from deficiencies in the
photo-protective response. This underscores the significance of comprehending the regulatory
mechanisms at play. Proper gene expression, epigenetic regulation, and the maintenance of
genome integrity hinge on the regulation of chromatin structure. In melanomas, mutations in
genes encoding components of the SWI/SNF Chromatin Remodeling Complex occur in 34% of
cases. However, the epigenetic consequences of the loss of SWI/SNF function following exposure
to UVR remain unclear. This proposal posits that the absence of BRG1, a catalytic subunit of the
SWI/SNF complex, disrupts the normal response of melanocytes to UVR. This leads to the
deregulation of gene expression and chromatin structure, compromising the photo-protective
response and exacerbating the inflammatory and other detrimental effects of UVR. To validate
this hypothesis, BRG1 will be inactivated in the melanocyte compartment of adult mice, and the
mice will be exposed to UVR. Our investigation will determine (Aim 1) the effects on gene
expression and (Aim 2) alterations in chromatin structure. This innovative study represents the
first to elucidate the impact of BRG1 loss in UVR-exposed melanocytes in vivo.

Public health relevance
An understanding of the melanocyte’s response to ultraviolet radiation (UVR) should increase our understanding of how exposure to this environmental carcinogen can lead to skin cancer. Thus, the proposed research is relevant to the part of NIH’s mission that pertains to acquiring the fundamental knowledge on how environmental exposures influence disease development. Acquisition of this knowledge is an important step toward reducing the burden of environmentally caused diseases.